Deep learning enhanced detection and personalized monitoring of aortic stenosis - The DETECT-AS Study

PROJECT SUMMARY
This is a new application by an early-stage investigator with a long-term career objective of transforming
cardiovascular care using artificial intelligence and data science. The proposal focuses on aortic stenosis (AS),
a progressive narrowing of the aortic valve, which manifests in older adults and causes significant disability and
premature mortality despite minimally invasive treatment strategies. AS is either diagnosed following symptom-
driven diagnostic testing or incidentally discovered, which has simultaneously led to a vast underdiagnosis of
advanced stages of AS while identifying many with early-stage aortic valve disease without clarity on appropriate
follow-up. There is a critical need for novel screening and prognostication strategies for AS. We show that artificial
intelligence (AI) models applied to 1-lead electrocardiograms (AI-ECGs) can be a sensitive and convenient
screen for advanced (moderate/severe) AS. AI-ECG can be paired with a second, more specific, AI-enhanced
handheld cardiac point-of-care ultrasound (POCUS). This AI-POCUS automates the diagnosis of advanced AS
without specialized imaging or expert evaluation. In Aim 1, we propose a multicenter pragmatic RCT evaluating
this 2-stage, AI-driven screening strategy for advanced AS. This innovative, technology-driven screening strategy
will define a new paradigm for the efficient identification of advanced AS. In addition, we evaluate a novel strategy
to bridge the critical gap in precision follow-up, especially for early-stage aortic valve disease. Early aortic valve
disease – aortic sclerosis or mild AS – affects nearly a fourth of older adults over 65 years. However, there are
no guideline recommendations on follow-up for aortic sclerosis, and recommendations for mild AS do not account
for the substantial heterogeneity in disease progression. In our preliminary investigations from a multicenter
observational cohort study, we show that a deep learning tool for echocardiographic videos – deep learning-
based aortic stenosis severity index (DASSi) – can define those at substantially elevated risk of progression to
advanced AS and adverse clinical outcomes. In Aim 2, we will conduct a multicenter, prospective evaluation of
an individualized AS progression score among older adults with aortic sclerosis or mild AS through a protocolized
Doppler echocardiogram to distinguish those with high and low rates of progression. The investigations in Aim 2
will establish the reliability of a digital biomarker for AS progression that can enable precision care and follow-
up. The work is supported by the team’s broad expertise in (a) clinical medicine, including cardiology, geriatrics,
and imaging; (b) technology, spanning informatics, data science, and AI; and (c) clinical trials, with experience in
designing and executing studies. The evidence generated from a multicenter evaluation of low-cost AI-driven
interventions can be immediately adopted and scaled to have a major public health impact. Moreover, an
objective approach to the diagnosis and follow-up of AS will reduce healthcare disparities for vulnerable patients.
Future work will build on these results and engage directly with communities using low-cost portable devices to
improve disease detection and outcomes among those without adequate healthcare access.

Public health relevance
PROJECT NARRATIVE Aortic stenosis (AS) is a progressive narrowing of the aortic valve that causes significant disability and premature mortality in older adults despite being treatable with a minimally invasive valve replacement procedure. The application proposes a multicenter randomized clinical trial evaluating a low-cost and practical artificial intelligence-based, 2-stage screening strategy for older adults that can detect advanced AS before the onset of symptoms. In addition, the concomitant challenge of a lack of a precision follow-up strategy for incidentally discovered early-stage aortic valve disease is addressed with a novel digital biomarker for AS progression that can define individuals at an elevated risk of rapid progression of AS.